Role of Gut Microbiome- Brain Axis in Modulating CNS Inflammasomes in the Neuropathology Produced by Opioid Exposure and HIV

Project Summary
Infection with Covid-19 has reached pandemic status with more than 125 million confirmed cases and 2.75
million deaths making it one of the most deadliest pandemics in history. It is associated with severe acute
respiratory syndrome symptoms with high fatality rates. SARS-CoV-2 infection is initiated when its S-protein
binds to the angiotensin-converting enzyme 2 (ACE2) receptor through which it gains entry into the host's cells
(Kuba et al., 2005; Walls et al., 2020). ACE2 is highly expressed in the in the lungs and to a lesser degree in
other organs, such as the heart, kidneys, and intestines (Bavishi et al., 2020), which explains the increased
prevalence of lung infection. An analysis of electronic health record data from more than 73 million patients
showed that people with SUDs are at higher risk of contracting and suffering worse consequences from COVID-
19 particularly among African Americans. Those with an opioid use disorder (OUD) were 2.4 times more likely
to have COVID-19 than those with cocaine use disorder (1.6 times), alcohol use disorder (1.4 times), and
tobacco use disorder (smoking or vaping; 1.3 times). Our recent preliminary data show that chronic opioid
treatment in a mouse model of opioid substance abuse resulted in significant increase in the expression ACE2
expression in the lungs and brain of these animals. This data suggests that long term exposure to opioids by
increasing ACE2 expression in the lung will increase the susceptibility to COVID 19 infection and its expression
in the brain suggests high likely hood of neuro-invasiveness. In this supplement we will test the hypothesis that
substance use disorders with opioids will increase the risk for COVID 19 infection in the lung and will be
associated with neuropathological consequence as a consequence of increased ACE2 expression in brain cells.
In Aim 1: We will investigate the expression of ACE2 in small intestine, lung and brain cells in both male and
female mice that are chronically treated with morphine. We will further investigate if substance abuse in context
of HIV further exacerbates infection and disease progression. In Aim 2; we will investigate using a humanized
mouse model where the murine ACE2 receptor is knocked in, the infectivity of the SARS-CoV2 Spike Protein-
Pseudotyped GFP using both in vitro and in vivo target cells. In Aim 3 we will investigate the role of the gut
microbiome in modulating ACE2 expression levels in the small intestine, lung and brain.

Public health relevance
Project Narrative The Covid 19 infection has reached pandemic proportion. Recent data suggests higher risk of Covid 19 death and fatality among opioid users. The mechanism underlying the increased susceptibility is not clear. The goal of this study is to establish that increased expression of the ACE2, the binding site COVID19 virus, opioid users contribute to increased susceptibility and infection with COVID19.